FASEB's "The Intestinal Lipid Metabolism Conference: In Health and Disease"

PROJECT SUMMARY Intestinal lipid metabolism is a flourishing area of research because of its importance in fundamental physiological processes and its roles in the development and treatment of disease. Launched in the early 1990s, the series Intestinal Lipid Transport and Metabolism Science Research Conferences (SRC), sponsored by FASEB, has focused on a range of themes that has included molecular, cellular, and integrative physiological studies of lipids and lipoproteins, chylomicron assembly and secretion, lipid transfer proteins, enzymes in lipid synthesis, intestinal lipid droplet formation and mobilization, and bile acid metabolism. The pivotal role of the intestine in the regulation of metabolic homeostasis has received increasing attention of the scientific community in recent years. In particular, the role of the gut microbiome has been under intense investigation over the last decade, and literature on the systemic effects of nutrients, bile acids, and gut hormones are prolific. Despite its importance and central role in metabolism, many open questions regarding intestinal lipid biology remain. Recognizing its importance, FASEB has agreed to sponsor a 2020 FASEB SRC in the series. Based in part on the interests expressed by potential attendees in an online survey conducted by the organizers (see more description of the survey below), this meeting will highlight cutting-edge advances, from molecular and cellular to organismal studies in intestinal biology and related metabolic diseases, presented by recognized and emerging leaders in the fields. It will include a keynote address (Mansbach Lecture), 8 oral and 2 poster presentation sessions, as well as a community introduction event, an “open mic” research sharing forum, and a career development workshop to facilitate scientific exchanges and networking. The long-term objective of this proposal is to advance fundamental areas of intestinal lipid metabolism research that have strong clinical and

Public health relevance
PROJECT NARRATIVE Intestinal lipid metabolism is a flourishing area of research because of its newly appreciated importance in fundamental physiological processes involved in the development and treatment of disease. The conference will cover emerging themes and cutting-edge concepts while providing forums for participants from a diverse research community to develop new ideas and foster collaborations to advance this important area of research. This project is to request funding to support investigators and trainees from women and other groups under- represented in research to attend and present in the 2020 FASEB conference on intestinal lipid metabolism.